Biomedical Research Core

Abstract
Pediatric Kidney BioMedical Core (pKidBIO Core)
Kidney disease is a major cause of illness and death in infants, children, and adolescents with the
incidence of end-stage kidney disease (ESKD) in these patients in the United States of about 15
per million. The rapidly increasing problems of adult hypertension and renal failure may also have
roots in pediatric kidney insults that go undetected, unprevented and untreated. The development
of effective interventions and methods of early detection and severity measurements of renal
disease in children is lagging in part due to a lack of knowledge of physiological and pathological
changes that occur as the kidney matures. Molecular blueprints would dramatically enhance our
ability to design effective approaches to intervene and prevent kidney dysfunction. This goal
cannot be met, however, without having a source of pediatric kidney tissue to begin molecular
interrogations to identify the, uniquely human and developmental, ’omic instructions required to
make and maintain healthy kidneys. The pKidBIO core, as part of the Washington University
Pediatric Center of Excellence, is in an unusually strong and unique position to provide the
required pediatric kidney tissues, originating from clinical biopsies or as “gifts of life” consented for
research, preserved with methods shown to be compatible with the most recent technologies to
enable age-specific research to dig into multi-omic single cell transcriptome and epigenome
assays, molecular imaging and tissue engineering. By its design and nature, the pKidBIO core will
promote enthusiasm and progress in pediatric kidney disease research by 1) providing human
age-specific references for fetal and childhood kidney disease tissues, 2) enabling studies aimed
to delineate cellular, morphological, physiological and molecular changes associated with postnatal
kidney maturation, 3) accelerating scientific research aimed at ex vivo human kidney organoids, 4)
establishing protocols for isolating differentiated kidney cell types at stages consistent with those
seen in kidney tissue samples, 5) advancing drug toxicity screening, and by 6) designing validation
studies of gene function and kidney engineering. The availability of the tissue and the outstanding
data generated from them will attract new expertise outside kidney research developing spatial
imaging and analytical technologies and research interested in physiological aging across the
lifespan. The pKidBIO repository will be a national resource for the research and clinical
community that is findable, accessible, interoperable, and reusable.